Non-Canonical Roles for Cell-Adhesion Molecules in Presynaptic Assembly

PROJECT SUMMARY
The proper formation of synapses is integral to the function of neural circuits. Disruptions in synaptogenesis
during early development can lead to neurodevelopmental disorders, such as autism or intellectual disability.
Yet despite decades of study, precisely how synapses form, mature, and are maintained has remained
elusive. Cell-adhesion molecules (CAMs) have been implicated in synaptogenesis, as their extracellular trans-
synaptic interactions are capable of inducing synapse assembly and conferring synaptic partner specificity.
However, the intracellular signaling pathways that mediate their synaptogenic functions are less understood.
Using the roundworm C. elegans, we have identified a pair of CAMs, SYG-1 and SYG-2, that may have non-
canonical roles in synapse assembly, functioning in the absence of trans-synaptic binding to regulate
presynaptic assembly. We have found that the intracellular domain of SYG-2 alone is sufficient for inducing
presynaptic assembly, in contrast to the accepted idea that the extracellular domains of CAMs are required for
their function. Using CRISPR transgenesis, I will determine whether this protein and its known binding partner
SYG-1 are required together or separately to organize presynaptic specializations. I will then mutate candidate
binding motifs within their intracellular domains to elucidate the downstream intracellular pathways required for
their function. These experiments will provide insight into the possible function and underlying mechanisms of
SYG-1/SYG-2 human ortholog KIRREL3, which has been implicated in autism.

Public health relevance
PROJECT NARRATIVE Neurodevelopmental disorders, such as autism, lead to many impairments that negatively affect an individual’s quality of life. Because defects in synaptogenesis, and in particular mutations in cell-adhesion molecules, are often implicated in these disorders, it is imperative we understand how this biological process occurs. This project aims to understand how two cell-adhesion molecules contribute to synaptogenesis, furthering our understanding of the process and providing insights for possible treatments.